HPDPRC SIP 13-66

Abstract This project will create the nation's first online system to help public health and cancer control organizations create their own versions of evidence-based interventions to promote breast and cervical cancer screening in low-income and underserved women. Make It Your Own, or MIYO, is a web-based platform on which users can create their own versions of small media and client reminders for the specific populations they serve. Users build these materials by choosing from a menu of proven approaches recommended by the Guide to Community Preventive Services, and customize them by choosing from a library of images, messages and graphic designs. MIYO then renders their creations into electronic documents that can be printed, e- mailed, texted, used online or distributed in other ways to target audiences. It has been used to promote HPV vaccination, colorectal cancer screening, use of tobacco quitlines and enrollment in cancer clinical trials. Our team created MIYO, and will follow a proven formula in developing new modules to promote breast and cervical cancer screening: (1) assessing needs of potential users; (2) building and audience testing an image library; (3) developing and audience testing a message library; (4) creating and audience testing prototype versions of evidence-based interventions; (5) uploading content to the MIYO platform and testing the system; and (6) launching the new MIYO. This tool will help grantees and their partners in the National Breast and Cervical Cancer Early Detection Program increase screening in vulnerable populations. !

Public health relevance
Significance This project will create the nation's first online system to help public health and cancer control organizations create their own versions of evidence-based interventions to promote breast and cervical cancer screening in low-income and underserved women. !